Biolibrary and Pathology

BIOLIBRARY & PATHOLOGY SHARED RESOURCE Directors: Devon Kelly, M.S. and George Thomas, M.D ABSTRACT/PROJECT SUMMARY The Knight Cancer Institute (Knight) sponsored BioLibrary & Pathology Shared Resource brings together tissue collection, processing, clinical annotation, and histopathology services into a single core. The unit provides members with: 1) a repository of well-annotated human tissue, blood and saliva, 2) a database of annotated clinical variables including patient demographics, treatments and clinical outcomes; research and clinical trial participation; genetic profiles, research analyses and specimen imaging, 3) tailored data in the form of client-specified case reports, 4) pathology services for studies on human and animal tissues, including cryostat sectioning, paraffin-embedding, microtome-sectioning, histochemical staining, immunohistochemistry, immunofluorescence and fluorescent in situ hybridization, 5) support in producing high quality RNA and DNA samples from both frozen and fixed specimens, and 6) pre-award consulting for preparation of grant and other funding applications. The BioLibrary & Pathology Shared Resource is accredited through the College of American Pathologists (CAP) and is Clinical Laboratory Improvement Amendments (CLIA) certified. It is staffed with members who have decades of combined experience in handling samples from small animals and human to ensure that tissues are properly prepared to meet the various needs of the research community, both for immediate analyses as well as long-term storage and use.